Iron Status at Perimenopause: Effects on Brain and Behavior

Project summary/abstract From the onset of menarche, through the child-bearing years, a substantial number of women worldwide are challenged by iron deﬁciency (ID) or iron deﬁciency anemia (IDA). The negative effects of ID include deﬁcits in cognitive and physical performance. At and following menopause, however, the nature of the relationship between iron status and both cognitive performance and brain health is much more ambiguous, and the literature on these relationships is quite sparse, in spite of evidence suggesting that brain iron accumulation may play a role in neural degeneration and cognitive decline. One intriguing potential regularity in the literature is an inverse relationship between systemic levels of ferritin and performance on a range of memory tasks in peri- and post-menopausal women. This suggests that amenorrhea may produce differential changes in brain iron for women who are ID or IDA at or prior to menopause relative to those who are not. There are at least two competing possibilities. First, when blood loss stops, brain iron levels may accelerate in a manner inversely proportional to systemic iron levels. For ID women, this may reverse any deﬁcits that may be due to ID, but accelerate the negative effects of iron deposits (including oxidative stress) in speciﬁc brain regions, including those critical to attention and memory. Second, the rate of brain iron accumulation may have no relationship to iron status at menopause. For women who are ID, this would mean that brain iron levels, although increasing over time (and thus, eventually, reversing any ID-related deﬁcits) would remain lower than those of women who are iron sufﬁcient (IS), possibly conferring a protective beneﬁt with respect to the adverse effects of accumulating iron on brain tissue and function. The ability to address these possibilities depends on the feasibility of measuring relationships among levels of iron in the blood, levels of iron in brain in regions known to be involved in speciﬁc aspects of cognition, brain dynamics during cognitive work and at rest, and behavioral measures of speciﬁc aspects of cognition. This project will be, to our knowledge, the ﬁrst to assess the feasibility of assessing all of these relationships. A set of non-anemic pre-, peri-, and post-menopausal women, half of whom have low levels of blood iron and half of whom are sufﬁcient, will provide structural brain scans for region-speciﬁc estimates of brain iron. They will be tested on behavioral measures of cognitive performance that selectively engage those regions while having brain activity measured using electroencephelography (EEG), and will also have EEG recorded during two periods of rest. All of this will allow for the ﬁrst known quantitative characterization of the relationships among blood and brain iron levels, brain dynamics (both at work and at rest), and behavior, all relative to the onset of menopause. This cross-sectional characterization will provide the data that are critically needed for an efﬁcient longitudinal examination of these questions, and will represent a unique contribution to a now-sparse literature on the relationship between iron and brain health and cognition in women in later life.

Public health relevance
Narrative From the onset of menarche, through the child-bearing years, a substantial number of women worldwide are challenged by iron deﬁciency, and the negative effects can include signiﬁcant reductions in measures of attention and memory. However, very little is known about the effects of iron deﬁciency at menopause. It is possible that a woman who is iron deﬁcient at menopause may be at a higher risk for the negative effects of iron accumulation in the brain in later life. However, it may also be the case that iron deﬁciency at menopause may protect a woman from these later-life risks. The proposed work will be the ﬁrst to combine measures of blood iron, brain iron, behavior, and brain dynamics to explore these two possibilities and will set the stage for a comprehensive longitudinal examination.